Role of plasma cells in chronic rejection after lung transplantation

SUMMARY
Lung transplantation (LTx) is the only life-saving intervention for many patients with end-stage
lung disease. The long-term survival after LTx, however, is severely limited primarily due to
chronic rejection of the allograft (chronic lung allograft dysfunction - CLAD). Bronchiolitis
obliterans syndrome (BOS) is the most frequent phenotype of CLAD. It is characterized by partial
to complete obliteration and luminal occlusion of distal airways and includes features of
subepithelial cellular inflammation, peribronchial and interstitial fibrosis, and selective loss of club
cells within the airway epithelium. The pathogenesis of CLAD remains poorly understood, largely
due to a lack of clinically relevant animal models, but includes influx and activation of cell
populations of the innate and acquired immune system, tissue remodelling, and distorted immune-
epithelial cell crosstalk. However, which specific immune cell populations drive tissue remodelling
in the transplanted lung remains unknown. We have recently discovered a significant increase in
B cell populations and Marginal Zone B And B1 Cell Specific Protein (MZB) 1-positive plasma
cells in rejected lungs, both in lungs from a novel mouse model of chronic rejection after orthotopic
LTx, as well as in retransplanted CLAD patients. We showed that an innate-like B-1B population
served as a progenitor pool of MZB1+ plasma cells and that B cell deficiency prevented chronic
rejection in mice. Systemic depletion of B cells, however, is associated with increased risks of
concomitant infections, in particular in patients routinely receiving high doses of
immunosuppressive regimen, such as LTx patients, thus requiring more nuanced approaches to
modify this pathogenic B and plasma cell populations. Therefore, the overarching goal of this
application is to define the spatiotemporal profile and cellular heterogeneity of MZB1+ B and
plasma cell populations over time after LTx and interrogate their mechanistic contribution to
chronic rejection by manipulation their abundance and function in vivo. We hypothesize that
plasma cells accumulate in chronically rejected lungs in peribronchial regions and cause
increased peribronchial fibrosis and decreased lung function in chronic rejection. To test this
hypothesis, we propose the following aims: Aim 1: To provide a comprehensive and detailed map
of B and plasma cell gene expression profiles, population heterogeneity, and temporal dynamics
in the chronically rejected lung after LTx. Aim 2: To mechanistically interrogate whether deletion
of MZB1 or blocking the differentiation of MZB1+ plasma cells from B-1B cells prevents tissue
fibrosis, lung function deterioration, and chronic rejection after orthotopic LTx in mice.

Public health relevance
PROJECT NARRATIVE Lung transplantation is the only life-saving intervention for many patients, but it is severely limited primarily due to chronic rejection of the allograft (CLAD). Our data show a significant increase in specific B and plasma cell populations in rejected lungs, both in lungs from a novel mouse model of chronic rejection after orthotopic lung transplantation, as well as in retransplanted CLAD patients. In this application, we will investigate the mechanism of their contribution to rejection and potential therapeutic application for these cell populations.